Genome and Phenome to Define Disease Risk with Antinuclear Antibodies

PROJECT SUMMARY
Antinuclear antibodies (ANA) are antibodies that react against self-antigens and are commonly used to help
diagnose systemic lupus erythematosus (SLE). Because the test is positive (ANA+) in almost every patient
with SLE— even years before the disease onset—a positive ANA test is considered virtually a requisite for the
diagnosis of SLE. However, the test is also positive in a large proportion of the general population (~20%).
Although very few of these ANA+ individuals will develop an autoimmune disease in the future, the clinical
impact of a positive ANA in people without autoimmune disease is unknown. A second problem is that the
common occurrence of ANA+ in people without autoimmune disease can lead to the problem of an incorrect
diagnosis of SLE, particularly if an ANA+ person also has joint or muscle pain. To more accurately diagnose
SLE and prevent false diagnoses, we need to address two major knowledge gaps: 1) we need to understand
the importance of a positive ANA test in people without an autoimmune disease; and 2) we need to be able to
predict which people with a positive ANA test have or will develop SLE.
In this study we will evaluate the overarching hypothesis that clinical and genetic information can: 1)
define the clinical consequences of positive ANA in people without autoimmune diseases, and 2)
improve risk prediction to differentiate people with increased risk of SLE. Thus, we proposed three
Specific Aims: 1) test the hypothesis that a positive ANA in people without autoimmune disease is associated
with clinical phenotypes (using a clinical and a genetic approach); 2) test the hypothesis that a clinical
prediction model will accurately discriminate patients with early SLE or who are at risk for SLE from among
those with positive ANA without an autoimmune disease; and 3) test the hypothesis that the combination of
genetic and clinical information will accurately discriminate patients at risk for SLE. To address these aims, we
will use the Vanderbilt University Medical Center Biobank (BioVU) and de-identified electronic health records
(EHR) to create genetic and clinical risk scores using state-of-the-art genetic techniques and data-driven
prediction tools.
The results of these studies could: a) define whether people with a positive ANA and no autoimmune disease
have an altered risk of illnesses that could be used to guide health-care decisions; and b) transform the care of
SLE by improving the accuracy of early-stage SLE diagnosis and identify patients at highest future risk. These
findings will help clinicians start treatment earlier to control inflammation and prevent damage and will
decrease the rates of misdiagnosis, thereby protecting patients from unnecessary therapies and their side
effects.

Public health relevance
PROJECT NARRATIVE – RELEVANCE Testing for antinuclear antibodies (ANA) is a common practice to screen for systemic lupus erythematosus, since the test is almost always positive in lupus even years before the disease onset. However, a large proportion of people without autoimmune disease also have a positive ANA test, and it is not known whether a positive test increases the risk for other adverse outcomes. This project aims (a) to discriminate who is at high risk for lupus from among individuals with a positive ANA test and (b) to define the risk for positive ANA individuals without an autoimmune disease in order to provide better health care advice and improve the care of lupus patients.